2023 Atherosclerosis

Abstract
The Gordon Research Conference (GRC) on Atherosclerosis has played a central role in this important field for
over 40 years. Although the themes evolve every two years, the format and qualities that make this meeting
exceptional are maintained: presentations of cutting-edge unpublished data from leading laboratories within the
field and in emerging areas, an environment that encourages open scientific exchange among established and
early career investigators from academia, industry and government, and an intimate and inclusive format (<200
attendees) that maximizes productive interactions and discussions between scientists. The goal of the
Atherosclerosis GRC conference is to provide a comprehensive overview of research at the cutting edge of the
field and the developing frontiers, including the latest and emerging paradigms, the most current techniques for
studying atherosclerosis in humans and animal models, and the most promising approaches to prevent and
treat cardiovascular disease. The theme of the 2023 meeting is `Molecular mechanisms, genomic modifiers
and emerging therapies'. We will: 1) Highlight novel techniques being used to investigate atherosclerosis
including high dimensional profiling and spatial organization of vascular and immune cells in the vessel wall, as
well as systems biology and machine learning approaches that analyze the atherosclerotic plaque as a whole
entity, rather than studying individual cell types as has been done in the past; 2) Discuss new molecular
pathways regulating vascular and immune cell function, mechanisms of atherosclerosis regression,
immunometabolism, clonal hematopoiesis and genetics of atherosclerosis; 3) Focus on complications of
atherosclerosis such as diabetes, myocardial infarction, stroke and neurodegeneration, and 4) Create an
inclusive meeting culture that fosters interactions between early and established investigators, welcomes
The program will also incorporate short talks
and posters from submitted abstracts to capture the latest results and provide ample presentation opportunities
for trainees and students. For the first time in 17 years, the Atherosclerosis GRC will be returning to a venue in
Europe: the Rey Don Jaime Grand Hotel in Castelldefels, Spain. This site is easily accessed from the United
States and Europe (20min from a major airport), and has comprehensive conference facilities, accessible to
disabled persons, that accommodate the formal and informal meetings, community meals, and social
interactions that make the GRC meetings unique. As the atherosclerosis community is an international group,
there has always been strong attendance by our European colleagues of the US-based GRC meetings, and
we are excited to bring the meeting closer to them this time. In summary, the Atherosclerosis GRC has been
thriving for over 40 years through the support of its strong scientific community and its guiding principles of
cutting-edge science, open discussion and inclusion.
underrepresented scientists and enables their voices to be heard.

Public health relevance
Narrative Atherosclerosis is the underlying cause of heart attack and stroke and remains a leading cause of death world- wide. The focus of the 2023 GRC on Atherosclerosis is to bring together thought leaders, postdoctoral fellows, and trainees to learn about the latest research in atherosclerosis and its complications. The diverse program crosses disciplines, touching on genetic, cellular, metabolic, and immune factors that contribute to the development of this disease.